Combined inhibition of ATR and p110β as Therapy in PTEN-deficient Prostate Cancer

Project Summary/Abstract
Given the high mortality of castration-resistant prostate cancer (CRPC) as a result of relapse after androgen
deprivation therapy (ADT), novel treatment strategies are urgently needed. Tumor suppressor gene-
phosphatase and tensin homolog (
PTEN) is mutated in approximately 20% of primary prostate cancers, and in
as many as 40~60% of CRPC. In addition to activation of PI3K oncogenic signaling pathway, loss of PTEN is
also associated with cytokine and chemokine signaling that creates an immunosuppressive microenvironment.
Both defects in antigen presentation in tumor cells and the immunosuppressive tumor microenvironment (TME)
have been implicated in CRPC progression after ADT and therapeutic resistance in prostate cancer in the clinic.
Genetic or pharmacologic inactivation of β isoform of PI3K (p110β) in PTEN-deficient prostate cancer has been
reported to significantly inhibit tumor growth and progression. Ataxia telangiectasia and Rad3-related (ATR)
exhibits essential functions in controlling DNA replication stress and DNA damage response in cancer cells.
PTEN-deficient cells have been reported to be more sensitive to ATR inhibition. PI3Kβ is also functionally
associated with DNA damage response and genomic integrity in tumor growth. By using a syngeneic genetically
engineered mouse model of CRPC driven by co-deletion of PTEN and TP53 (PP-CRPC), we found that addition
of p110β inhibitor significantly reduces the viability of ATR inhibitor-treated PP-CRPC cells. Moreover, our
preliminary data show that inhibition of p110β or ATR alone significantly increases MHC class I antigen
presentation in mouse or human CRPC cells. Based on these novel preliminary data, we hypothesize that p110β
inhibitor in combination with ATR inhibitor will show promising anti-tumor activity in PTEN-deficient CRPC via
inducing cell death in cancer cells and anti-tumor immunity in the tumor microenvironment. We also hypothesize
that inhibition of p110β will increase DNA replication stress and sensitize PTEN-deficient CRPC cells to ATR
inhibition. In this study, we will
1)
evaluate the therapeutic efficacy and antitumor immune responses of combined
ATR inhibition and p110β
inhibition i
n syngeneic PTEN-deficient CRPC mouse models; 2) investigate the
molecular mechanisms of the combined effect of ATR inhibitor and p110β
inhibitor in replication stress and DNA
damage-induced cell death in PTEN-deficient CRPC cells.
Our study will not only provide fundamental
information for translational research of p110β inhibitors and ATR inhibitors in cancer treatment, but also provide
a novel treatment strategy for patients with PTEN-deficient advanced CRPC.

Public health relevance
Project Narrative The proposed research is designed to p110β and ATR in PTEN-deficient CRPC mouse models and to investigate the underlying molecular mechanisms of combined effect of ATR inhibitor and p110β evaluate the anti-tumor activity and immunity of combined inhibition of inhibitor in DNA damage-induced cells death in PTEN-deficient CRPC cells . Our research will potentially provide fundamental evidence of DNA damage-induced cell death and anti-tumor immunity in PTEN-deficient CRPC after inhibition of p110β and ATR, and a novel mechanism-based combination therapy to treat CRPC patients harboring genetic alterations of PTEN.